Disabling the replication-competent HIV provirus in the reservoir by combined CRISPR-Cas action

Summary. DNA can be targeted by the CRISPR-
Cas (CC) genome editing tool, which was swiftly
implemented in anti-HIV studies1-8. We confirmed
potent HIV inhibition, but also demonstrated rapid
virus escape from CC attack9. Inspection of the
escape viruses indicated a role of the NHEJ
enzyme, which repairs dsDNA breaks and
introduces small insertions/deletions (indels) in the
process. In other words, we described a novel viral
escape route that is facilitated by a cellular DNA
repair process. These results were confirmed by
other labs10-21. A combinatorial CC attack against
conserved sequences triggered HIV inactivation
through hypermutation, quite different from the
proposed excision route (Fig 1). Although provirus
excision could be detected in our system, it
occurred with a very low efficiency. Instead, CC
attack generated hypermutated proviruses that
apparently lost all replication potential. In other
words, continuous CC action can functionally
CURE HIV infected cells, leaving the cells with a
graveyard of inactivated HIV proviruses. This
surprise finding represents a major hallmark in HIV
CURE studies. We now propose to first delineate
the underlying mechanisms and variables that
determine the outcome of CC attack (HIV excision
versus hypermutation). This will allow us to
formulate the best CURE strategy. At the same time we focus on the major obstacle towards a CURE:
delivery of the gene therapeutics to cells that compose the HIV-reservoir. The CC and delivery tools
will then be combined for in vivo CURE studies in the HIS mouse.

Public health relevance
Narrative CRISPR-Cas can inactivate integrated HIV DNA genomes, but two sterilization mechanisms have been proposed (excision versus hypermutation, see Fig 1). We will perform research to delineate the underlying mechanism that should allow us to formulate the most robust and safe CURE strategy. We next focus on the major obstacle towards a CURE: specific delivery to cells that compose the HIV- reservoir, which eventually will be tested in the humanized immune system (HIS) mouse.